Human Immune Monitoring Core

ABSTRACT – Human Immune Monitoring Core
The Human Immune Monitoring Core will support the Stanford HIPC projects with standardized, state-of-the-
art, comprehensive immune monitoring services for the clinical samples collected across all three clinical
studies in this application. The Core will leverage the considerable infrastructure of the Human Immune
Monitoring Center at Stanford, which has all the necessary space, equipment, expertise, and personnel to
conduct these assays. Specifically, the Core will provide: (1) Olink immunoassays on serum, using their
inflammation panel of 92 cytokines and related molecules; (2) CyTOF PBMC phenotyping with intracellular
cytokine staining (CyTOF ICS) and EpiTOF assays for DNA methylation in specific immune cell subsets; (3)
BD Rhapsody single-cell transcriptomics assays with AbSeq and TCR targeting; and (4) Luminex assays for
antibodies to SARS-CoV-2 proteins and antigens of other heterologous viruses. Data from these assays will be
organized, mapped to clinical demographics, and shared with the Data Management and Analysis Core, using
our Stanford Data Miner online database. This will also facilitate the upload of these data sets to ImmPort. We
anticipate that the data generated through the Core will be a resource to be mined well beyond the limits of the
HIPC grant.